Metabolic effects of interrupting sedentary time in youth in-lab and in free-living settings

ABSTRACT Sedentary behavior (SB) contributes to increased type 2 diabetes risk over the lifespan. Interrupting SB is a promising strategy to reduce risk, but the long-term efficacy is not yet clear and data on the relationship between in-lab and free-living metabolic responses are lacking. The goal of this proposal is to provide training in physiologic consequences of SB, field-based assessments of glucose responses to interrupting SB via continuous glucose monitoring, and advanced multi-level statistical methods to study the moderators and the effectiveness of SB interruptions on glucose homeostasis in both in-lab and free-living contexts, yielding data important for the development of targeted type 2 diabetes prevention intervention strategies. Mentored training will consist of: (1) training in expertise in longitudinal study design and field-based data collection techniques in youth; 2) the pathophysiology of type 2 diabetes; 3) the use of advanced statistical modeling techniques to analyze longitudinal variations in energy balance behaviors as they relate to metabolic outcomes; and 4) the design of field-based intervention strategies to improve and address type 2 diabetes-related physiologic mechanisms. Dr. Michael Goral (co-primary mentor) is an expert in the causes and consequences of childhood obesity and type 2 diabetes risk factors in youth. Dr. Genevieve Dunton (co-primary mentor) is an expert in field-based energy balance behavior assessment and longitudinal study methodology. Drs. Jimi Huh and Kathleen Page (co-mentors) are experts in statistical models for health behavior research, and endocrinology and type 2 diabetes pathogenesis. Specific Aim 1 tests the hypothesis that individual-level factors modify in- lab and free-living metabolic response to experimental conditions. Specific Aim 2 tests the hypothesis that the magnitude of in-lab glucose responses to SB interruptions will be associated with the magnitude of free-living glucose responses to SB interruptions over 4 days in a subsample (N= 12). Participants (28 normal weight, 28 overweight/obese; ages 11-15) from an ongoing observational study (N=202) will complete an in-lab randomized crossover trial of acute metabolic responses to prolonged vs. SB interruptions; and a subset (6 healthy weight, 6 overweight/obese) will complete two 4-day study of effects of free-living habitual activity vs. device-prompted SB interruptions on glucose homeostasis. In-lab studies can help elucidate physiologic mechanisms of SB interruptions, but are limited in their non-naturalistic and highly controlled nature. Understanding the longer-term efficacy and physiologic consequences of interrupting SB is essential for the design of effective intervention strategies to prevent type 2 diabetes in youth.

Public health relevance
PROJECT NARRATIVE The aim of this study is to investigate whether the metabolic responses to interrupting sitting are the same in a controlled lab setting and a free-living setting. This study will also try to explain why some children respond better to these short interruptions in sitting than others by using three years of physical activity, body fat, and weight trajectory data from an ongoing study. A better understanding of the relationship between metabolic responses to sitting and interrupting sitting in the lab and in a naturalistic environment will help us design effective and targeted intervention strategies to prevent type 2 diabetes in youth.